Protein methylation pathways that control genetic susceptibility to environmental pollutants in the occurrence of craniofacial defects

PROJECT SUMMARY / ABSTRACT
Formation of the head and face is a complex process that is highly susceptible to disturbance as evidenced by
the high incidence of craniofacial birth defects. Dysregulation in genetic and environmental factors are the main
causes of craniofacial defects. However, less than 50% of craniofacial defect cases have identified genetic
causes, and mechanisms of gene-environment interaction remains poorly understood. Therefore, molecular
investigation is needed to increase understanding of craniofacial development. We recently identified a new
regulator of craniofacial morphogenesis that interacts with environmental stress. This regulator, Protein
Arginine Methyltransferase 1 (PRMT1), is an enzyme that methylates histone to generate a transcriptional
activation mark H4R3me2a and methylation non-histone proteins on arginine residues. Prmt1 ablation in
neural crest cells caused cleft palate and skull malformation. We further uncovered a role for PRMT1 in
guarding against environmental toxin TCDD-induced cleft palate. In this proposal, we aim to determine
PRMT1-dependent transcription and epigenetic mechanisms that regulated TCDD-induced cellular changes
and developmental defects, using mouse genetic models, biochemical and cell biology approaches, RNA-seq,
ChIP-seq and bioinformatic analysis.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to the public health because craniofacial malformations, including cleft palate and congenital skull deformity, are among the most common birth defects. Our proposed study aims to improve the understanding how these craniofacial malformations occur and how the occurrence can be affected by environmental pollutants. Discovery from the study will help provide new strategies to prevent or decrease the risk of birth defects and inspire the development of novel therapeutic options.